HYPERTENSION OPTIMAL TREATMENT STUDY

The major goal of this multi-center, international study currently in progress is to determine the best level of control for diastolic blood pressure in treated hypertensive patients with regard to mortality and morbidity.